Research and Evaluation Support Core Unit (RESCU Core)

METHODOLOGY CORE
ABSTRACT
The Methodology Core of the CCCR will bring together investigators from diverse scientific backgrounds whose
research interests are in the specific diseases of focus for this CCCR, osteoarthritis and gout, along with interests
in spondyloarthritis, scleroderma, osteoporosis and musculoskeletal pain. By having rheumatology, rehabilitation
and epidemiology and biostatistics investigators meet once a week together, the Methodology Core creates
interdisciplinary conversations and makes available to clinician researchers methodologic expertise that would
otherwise not be part of their grants or scientific projects. As in the prior MCRC, there is a focus in the
Methodology Core on epidemiologic studies of established and new cohorts in osteoarthritis and gout. In
addition, in the past five years we have developed expertise in addressing epidemiologic questions using large
electronic health record databases, especially the Health Improvement Network (THIN). The Boston University
CCCR group is well known for training young investigators, many of whom now make up a large segment of the
clinical researchers in rheumatology domestically and around the world. The Methodology Core will continue to
emphasize training doctoral and postdoctoral students and rheumatology fellows.
The overall goals of this methodology core are to provide state of the art methodologic input into clinical research
questions in OA, gout and other diseases we study and also to introduce new impactful clinical research methods
into the study of these diseases. In addition to providing support for study protocols, design and statistical
analysis, modern epidemiologic methods involving causal inference and Mendelian randomization will be used.
Further, because they represent major components of the future of clinical research in CCCR diseases, we will
include new expertise in machine learning and mobile health technologies.